Vascular Pyruvate Kinase M2 in Hypertension

Hypertension is the most significant health burden for society in terms of economic and health costs due to the
increased risk for cardiovascular disease (CVD) such as myocardial infarction and stroke. Patients with
hypertension have significantly greater risks for cardiovascular mortality and morbidity compared to age matched
normotensive subjects, even when the patient’s blood pressure is controlled with medication. Therefore, the
long-term goal of our application is to investigate the core mechanism of vascular remodeling associated with
hypertension so that an effective add-on therapy can be explored for patients with hypertension. Metabolic shift
to glycolysis has been recognized in many types of CVD including hypertension. However, limited information
is available regarding the types of cells influenced, if it contributes to hypertension or remodeling, as well as
critical mechanisms involved. The renin-angiotensin system (RAS) is considered to play a central role in
hypertension as well as the associated cell phenotypes including a metabolic shift to glycolysis. While the RAS
affects a variety of cells, and hypertension demonstrates a complex pathophysiology, our published data with
vascular smooth muscle cell (VSMC) AT1A receptor deficient mice have demonstrated a critical role of VSMC
signaling in angiotensin II (AngII)-dependent vascular remodeling. Accordingly, in this application, we will
explore the essential glycolytic enzyme pyruvate kinase M2 (PKM2) activation in VSMC via AngII that uniquely
mediates vascular remodeling and hypertension involving alterations in conductance as well as resistance
arteries. Based on promising preliminary data, we propose a central hypothesis that the VSMC PKM2 mediates
hypertension and vascular remodeling in conductance and resistance arteries, which likely involves both
metabolic and non-metabolic effects via its pyruvate kinase and specific protein kinase activities. Three specific
Aims are proposed to explore the vascular mechanisms and the relevance of their signal communication utilizing
an AngII model of hypertension as well as aortic VSMC and fibroblasts in vitro.
Aim 1 will study involvement of PKM2 activation in VSMC in hypertension and vascular remodeling.
Aim 2 will study novel mechanisms of how PKM2 activation in VSMC, glycolysis dependently and independently,
mediates hypertension and vascular remodeling.
Aim 3 will explore VSMC-to-fibroblast communication in hypertensive vascular fibrosis via VSMC PKM2
mediated hypertension-associated secretory phenotype (HASP) including Esm1.
To study the cell type and mechanism by which PKM2 is involved in hypertension and hypertensive vascular
remodeling, we will utilize genetically or pharmacologically altered mice infused with AngII. Accomplishing the
proposed aims will yield significant advancement of our knowledge and understanding of the mechanisms
leading to the development of hypertensive vascular remodeling and provide future translational research leading
to new therapies.

Public health relevance
Narrative Hypertension is a significant cause of death and disabilities associated with cardiovascular disease. No sufficient pharmacological treatment has been established for hypertension risks and complications such as vascular fibrosis. We propose rodent models to test our hypothesis that glucose metabolism in vascular cell types form a core mechanism which contributes to vascular disease associated with hypertension.